PHASE I STUDY OF RHU, IL-1 ADMINISTERED SUBCUTANEOUSLY TO ARTHRITIS PATIENTS

All patients have been enrolled and the study is now complete. The objective of this protocol was to determine the safety and efficacy of recombinant interleukin-1 Receptor in patients with active rheumatoid arthritis. All data has been collected and is now being analyzed. We have no analysis yet of the data collected as part of this study. It should be forthcoming within the next month.